Perinatal Mood and Anxiety Learning Laboratory in a Freestanding Children's Hospital

PROJECT SUMMARY/ABSTRACT
Postpartum depression (PPD) is the most common medical complication of childbirth that remains
underrecognized and undertreated. Children’s Hospitals are ideal sites for postpartum mental healthcare
because mothers in the Neonatal Intensive Care Unit (NICU) are at high risk and those seeking care in the
Pediatric Emergency Department (PED) often miss routine office visits with a pediatrician or obstetrician. The
first step to reducing the negative consequences associated with untreated PPD is timely screening and self-
awareness of depressive symptoms. However, screening NICU mothers and in the PED is uncommon,
expensive, personnel-heavy, and time-consuming. The second step is referral and treatment which is
multifaceted and requires parents to navigate different parts of the healthcare system, a vast endeavor for a
depressed individual. Redesign of healthcare systems to permit seamless screening, referral, and treatment of
mothers with PPD creating an efficient “one-stop-shop solution” is urgently needed. Our long-term goal is to
provide safe, comprehensive, point-of-care access to mental health services for parents of infants treated in
children’s hospitals. The overall objective is to create a Perinatal Mood and Anxiety Disorder (PMAD) Learning
Laboratory using a five-phase systems engineering approach that develops new solutions for clinical
recognition and therapy for PPD. Our specific aims are 1. To optimize screening, referral, and treatment for
postpartum depression in the NICU and PED using system dynamics group model building techniques. We will
analyze the current workflow, identify barriers, elicit system requirements from stakeholders, map the system,
and develop a system dynamics simulation model to test solutions in a virtual environment. 2. To design a
novel software dashboard for real-time tracking of eligible mothers with its accompanying parent-facing app
and develop a predictive model to identify at-risk mothers. We will then develop a measurement system to
monitor key performance indicators. 3. To implement new solutions, monitor, and evaluate the system for
unintended consequences before and after implementation. A difference in difference, and cost-benefit
analysis will be conducted to evaluate the changes. Our PMAD Learning Lab is innovative because it is a
significant departure from traditional techniques using novel approaches and new technology to assist in the
recognition and treatment of PPD on a large scale in real-world settings in the NICU and PED of a free-
standing children’s hospital. This is significant because if successful it will be generalizable to the treatment of
other mental health disorders that affect postpartum parents and will contribute to improvement in short- and
long-term health outcomes of parents and infants who are at a higher risk than the general maternal
population.

Public health relevance
PROJECT NARRATIVE The Perinatal Mood and Anxiety Disorder Learning Laboratory at Children’s National will redesign postpartum maternal mental health care, develop new technology for patient-provider communication, allow benchmarking and systems monitoring, and evaluate system threats and costs. This is a critical next step that brings us closer to new comprehensive, point-of-care maternal mental health care models on a large scale. The project is relevant to AHRQ’s call for using systems engineering approaches by multidisciplinary healthcare teams to test innovative solutions that improve quality and can be replicated and disseminated to improve outcomes for mothers and infants.